The function of chromatin remodeling in the patterning of the salamander limb

PROJECT SUMMARY
Injured mammalian limb cells are limited in their ability to respond to regenerative signals, and the goal
of this project is to contribute to identifying roadblocks to regenerative competency by studying how this property
is naturally induced in axolotl limb cells. Working toward this goal, this research focuses on how axolotl limb cells
become competent to respond to signals that organize, or pattern, the missing limb structure. The complexity of
the cell populations and signals that are in amputation blastemas has been a key challenge to studying patterning
competency in the past, and this research employs a new simplified regenerative paradigm called the CALM that
specifically assays this cellular property. Preliminary data using the CALM show that a combination of FGF and
BMP signaling is sufficient to induce patterning competency in limb wound cells, the Nrg1/ErBB pathway is a
downstream epigenetic regulatory target of these signals during this process, and that cells from different limb
locations respond uniquely to both inductive and patterning signals. While it is known that FGF/BMP are crucial
in the induction of patterning competency, several unknowns prevent our mechanistic understanding of this
including: 1) what are the pathways downstream of FGF/BMP that are fundamental in this process, and 2) how
does A and P positional information mediate different responses to BMP/FGF signals, in particular gene
expression regulation. To address these gaps, our approach objectives are: (Aim 1) to test the requirement and
sufficiency of Nrg1/ErBB signaling in the induction of patterning competency and identify the downstream gene
targets and (Aim 2) to identify the pathways activated by FGF and BMP ligands that are required for the induction
of patterning competency and the effect of positional information on the downstream gene regulations. The data
collected will resolve the upstream pathways that regulate competency, and how positional context influences
the cellular responses to inductive signals. In addition to enhancing our understanding of the molecular
underpinnings of regenerative competency in limb cells, the proposed research has been specifically designed
for the inclusion of undergraduate researchers to provide students with hands-on research experiences.

Public health relevance
PROJECT NARRATIVE: The long-term goal of this research is to promote the natural regenerative ability of cells in human limbs by enhancing their ability to respond to regenerative signals. Working toward this goal, this project will focus on the molecular underpinnings of how limb cells in the model organism, the axolotl, become competent to the signals that organize the regenerating cells into the missing limb structures.